SUBSTRACTED CDNA CLONING AND SUBSTRACTED CDNA PROBES

We are trying to molecularly characterize transformed cells versus normal cells on an expression level. One approach to achieve this goal is to make a substracted cDNA library which should contain only genes expressed in one but not in the other cell type. Another possibility is to make a P32-labeled substracted cDNA probe which can be used to screen a genomic library.